Interrogating roles for REST in small cell lung cancer therapy response and resistance

SUMMARY
Small cell lung cancer (SCLC) is a lethal tumor type characterized by exquisite response to chemotherapy
followed by rapid emergence of chemoresistance. Addition of PDL-1 inhibition to platinum/etoposide
chemotherapy leads to improved clinical responses but only a small subset of SCLC patients benefit. Distinct
subsets of SCLC have been identified including high-neuroendocrine and low-neuroendocrine (NE) subtypes.
High-NE SCLC, expressing high levels of ASCL1 (SCLC-A) or NEUROD1 (SCLC-N) is best understood, with
genetically engineered mouse models available. However, our understanding of low-NE subtypes is poor, owing
in part to a lack of mouse models. A low-NE immune “inflamed” subset of SCLC (SCLC-I) exhibited increased
response to immune checkpoint blockade and high expression of RE-1 Silencing Element (REST), a suppressor
of neuronal and neuroendocrine gene expression. Aim 1 tests hypotheses that REST overexpression in a
mouse model of SCLC will result in low-NE SCLC and that REST increases immunogenicity. We will use gain
and loss of function studies to dissect the contribution of REST to SCLC and to model low-NE SCLC. RNA-seq
analyses will use data from mouse GEM models and isogenic cell lines with REST perturbation to identify genes
consistently regulated by REST while CUT&RUN will identify direct targets of REST. We will perform gain and
loss of function studies to assess pathways through which REST alters the biology of SCLC, with an initial focus
on how REST controls the expression of MHC-I. Aim 2 builds from our preliminary data that implicate REST
expression in driving chemotherapy resistance. We performed an in vivo functional CRISPR activation
(CRISPRa) screen to identify genes that switch chemosensitive patient derived xenograft (PDX) models to
become chemoresistant when overexpressed and among the top screen hits was REST. We will study the
impact of REST perturbation on chemotherapy response and will test our hypothesis that REST expression will
cause a switch to chemoresistance. We will perform immunohistochemistry and molecular analyses to
characterize the response of REST-perturbed PDX models to chemotherapy in vivo. With the increased
appreciation of low-NE SCLC but poor understanding of the underlying biology, it is critical that this important
subset of SCLC be modelled and understood. This proposal provides new in vivo GEM and PDX models of low-
NE SCLC, which are essential reagents to link biologically distinct SCLC subsets to the most promising
therapeutic approaches.

Public health relevance
Project Narrative Small cell lung cancer (SCLC) exhibits distinct biological subsets, including strongly neuroendocrine and low neuroendocrine (low-NE) subsets, with recent data linking low-NE SCLC to improved responses to immune checkpoint blockade in patients. Lack of mouse models of low NE-SCLC has been a barrier to progress in the field, which we will overcome using mouse models that overexpress the REST repressor of neural/neuroendocrine state. Our preliminary data also link REST to chemotherapy resistance; we will model low-NE SCLC and test the impact of REST activity on responses to chemotherapy and immune checkpoint blockade.